Shared Resource Management

The Rogel Cancer Center (Rogel) Shared Resources (SR) provide technical expertise, state-of-the-art
technologies, data analysis, and training to meet Rogel members’ wide-ranging scientific needs and facilitate
research directed toward Rogel’s scientific themes. Rogel manages thirteen SRs and is proposing two
developing SRs in this application. The SR management team, consisting of the Associate Director for SRs
(ADSR), the SR Administrative Manager, and the Rogel Director of Finance, oversee SR scientific quality,
accessibility, operations, budgets, and cost-effectiveness. Additionally, the management team works with
Rogel members through meetings and surveys to determine members’ future SR needs and to identify those
services that are no longer needed. As a member of the Rogel Senior Leadership Council, the ADSR presents
survey results and SR data to senior leadership for discussion and decisions. Examples include successful
progression of the Single Cell Spatial Analysis developing SR and the Proteomics SR to full SRs; the
discontinuation of computational imaging in the newly renamed and refocused Preclinical Molecular Imaging
SR; and proposed establishment of the Liquid Biopsy and Epigenetics and Epigenomics developing SRs.
Rogel SRs serve all of the Rogel Research Programs. The annual operating budget of the combined Rogelsupported SRs is derived from institution support (i.e., Medical School, Rogel, and departments), and other
sources (e.g., chargebacks, other grants, and contracts) in addition to CCSG support. Thus, the CCSG
supports a fraction the overall operating expenses of the SRs demonstrating strong leveraging of these robust
and manifold funding mechanisms for Rogel SRs. To continue providing innovative and effective support to
Rogel members we propose the following specific aims: (Aim 1) Provide relevant, distinctive, and innovative
expertise and services that enhance research capability and members’ collaborations; (Aim 2) Ensure
accessibility, stability, reliability, quality, accountability, and cost effectiveness of SRs; (Aim 3) Forecast and
meet future scientific SR needs of Rogel members. We will achieve these aims through a combination of
communication with users and SR staff; critical evaluation of SR-relevant metrics; and input from senior
leadership, Program leaders and advisory boards. Through these activities, Rogel SRs will continue to provide
services that are critical to Rogel member research and to the Rogel mission.